Advanced Research Training in SDOH (ART)

PROJECT SUMMARY
Interdisciplinary researchers at Emory University propose to plan and execute a program on Advanced
Research Training in SDOH (ART). The primary goals are to increase the number of nurse scientists, and
scientists in aligned fields prepared to conduct research on the powerful ways that SDOH influences the health
of individuals, families, and communities and to increase the numbers of investigators that are poised to
conduct research in alignment with NINR’s strategic plan. The program builds on an outstanding research
infrastructure focused on SDOH and will be a logical and powerful extension of a four-year initiative launched
in the Nell Hodgson Woodruff School of Nursing to thoroughly integrate SDOH knowledge throughout our
curriculum. The ART program in SDOH will provide early-career faculty a mentored, educational program to
foster their transition to independent investigators with advanced skills in research methods relevant to SDOH.
ART will also provide mid-career faculty a training opportunity to integrate SDOH into their established
programs of research and to emerge as scientific leaders in SDOH. Trainees will be chosen who have interest
and alignment with our research strengths in SDOH including cancer, cardiovascular disease, aging and
cognition, climate change and behavioral health. In addition, our Center for Data Science and our Office for
Nursing Research provides a rich milieu to expose trainees to new methodologies being developed to capture
the impact of SDOH. The ART program consists of developing and implementing a Short Course in Research
Methods Related to SDOH content that will incorporate fundamentals of conceptual models; review of current
evidence related to SDOH topics and the impacts of this evidence on health disparities and health inequities;
relevant research methods critical to knowledge gaps in SDOH; and guidance on the development and
maintenance of successful transdisciplinary research collaborations. Trainees will be provided hands-on
research training by NIH-funded faculty at Emory University Schools of Nursing and Public Health on SDOH
related research topics. The program is envisioned to establish the basis of a long-term mentorship program
with our faculty in which trainees will be supported in continued development in obtaining NIH R-level research
funding relevant to SDOH. Moreover, the nurse scientists and those in related fields will be trained to be
ethically and critically engaged in SDOH research. They will emerge as trailblazers in SDOH research,
champions of multi-dimensional preventive strategies, and experts in advanced research methodologies,
setting new paradigms in nursing and related sciences.

Public health relevance
NARRATIVE The proposed project is to develop an educational program to train nurse scientists and scientists in aligned disciplines to conduct research focused on Social Determinants of Health. This program is alignment with NINR’s strategic plan to increase the numbers of investigators that are trained to be ethically and critically engaged in SDOH research and to ultimately decrease the health inequities experienced among underrepresented groups.